COMPLICATIONS AND TREATMENT OF IRON OVERLOAD IN TRANSFUSED PATIENTS

This project will evaluate the toxic effects of iron overload, and the efficacy of iron chelation treatments in patients receiving chronic transfusions.